Multiscale coordination of planar cell polarity

PROJECT SUMMARY
Planar cell polarity (PCP) is an ancient and near universal property of epithelial tissues in which subcellular
protrusions and membrane-associated proteins asymmetrically localize and align within a tissue plane. PCP
enables polarized cell behaviors such as directed cilia beating and collective cell motility, and mutations in PCP
pathway components cause severe developmental malformations in mammals and structural birth defects in
humans. Despite its ubiquity across species and its importance in embryonic development, basic principles of
PCP establishment remain unknown, including how symmetry is initially broken, whether cell contact is required
for asymmetry, and what is the minimal number of cells required to establish PCP. Our lab has developed the
mouse epidermis as a powerful model system with which to decipher fundamental and conserved principles of
PCP as well as mammalian innovations in the pathway. We have developed methods to perform long-term live
imaging, FRAP, and super-resolution microscopy using endogenously-tagged PCP reporters. Together with
strategies to generate mosaics and chimeras, the mouse skin is now on par with Drosophila in terms of genetic
tools and techniques to study PCP, but in a mammalian system. Using these tools, our lab has directly addressed
the question of how many cells are required to establish PCP. Inherent in this question is whether PCP proteins
can partition cell autonomously, or if intercellular binding of PCP components between cells was necessary to
initiate the process. Using chimeric mouse embryos in which dual-PCP reporter cells have been genetically
uncoupled from their neighbors, we found that in the absence of intercellular interactions, PCP proteins do not
polarize cell autonomously. Further, we demonstrated that intercellular binding of Celsr1 between just two cells
is both necessary and sufficient to initiate the sorting of PCP complexes into asymmetric bridges, and formation
of two Celsr1-enriched edges is sufficient to generate cellular-level asymmetry. Thus, intercellular binding of
PCP complexes is the critical step that initiates sorting of opposing PCP complexes to generate
asymmetry. Building on this discovery, this proposal seeks to define the molecular events downstream of Celsr1
homotypic binding that initiate the sorting of PCP complexes into asymmetric localizations (Aim 1), define the
roles of cytosolic components Dvl and Pk and their phase separating behaviors in the process (Aim 2), and
elucidate the molecular basis of Celsr1 asymmetric bridges (Aim 3). Combining state-of-the art genome
engineering approaches, advanced live and super-resolution imaging combined with classic embryological
approaches to generate embryos consisting of genetically distinct cells, successful completion of these aims with
define the molecular mechanisms that break symmetry and amplify polarity during PCP establishment.

Public health relevance
PROJECT NARRATIVE The ability of stem cells to self-organize into tissues and organ-like structures in a dish holds great promise for regenerative medicine. However, today’s organoid models often lack the long-range collective alignment of cell polarity, or planar cell polarity (PCP), an essential feature of native epithelial tissues. Our proposal will harness the experimental advantages of the murine epidermis to define fundamental mechanisms by which cells break symmetry and align their polarity across tissues.